Cancer Center Administration

The Abramson Cancer Center (ACC) Administration provides centralized coordination of resources and services required to facilitate the ACC's scientific mission to reduce the burden of cancer. Coordinated activities include: support for scientific strategic planning and evaluation, coordination of research program activities, support and oversight of shared facilities, implementation of ACC policies including space and membership, financial management and monitoring, coordination of the ACC pilot projects program, support for education and outreach activities, management of member information databases, and monitoring and reporting for these activities. The ACC Administration is comprised of a cohesive group of highly experienced staff with the demonstrated expertise needed to support the growing research needs of the membership. These key administrative staff members have clearly defined roles and responsibilities, ensuring that the administrative needs of the ACC and its constituents are addressed in an effective and efficient manner. ACC Administration provides vital support to the ACC Director, Senior Leadership, Program Leaders, Advisory Groups, ACC Shared Resources, and ACC members. During the current project period, the ACC administration has played an increasingly important role within the School of Medicine and the Health System, as the volume of clinical care and research has grown with the expansion of both the Adult and Children's Hospitals, the opening of the new outpatient facility within the Perelman Center for Advanced Medicine, and the opening of the Roberts Proton Therapy facility. New activities have included the selection and management of a new clinical trials management system, implementation of a tumor registry, and oversight of the ACC's information technology (IT) infrastructure. The responsibilities of the ACC administration have grown in parallel with the needs of an increasingly active membership and expanding research base, as well as the added responsibilities of managing a greater portion of the ACC's clinical and clinical research activities. It is anticipated that these responsibilities will continue to grow during the next project period. This CCSG budget represents 19% of the total ACC Administration budget and represents less than 10% of the total CCSG budget.